Patient-Oriented Research in Arginine Deficiency Syndromes

This K24 renewal application entitled “Patient-Oriented Research (POR) in Arginine (ARG) Deficiency
Syndromes” seeks 5 years of additional support for protected time to maintain the principle investigator’s (PI)
mentoring activities, promote her career development & provide ongoing momentum to advance the applicant’s
research evaluating ARG therapy in sickle cell disease (SCD) and beyond. ARG is a nutritional supplement &
obligate substrate for the production of nitric oxide, a potent vasodilator that becomes depleted during episodes
of SCD-related pain. The PI & her mentees have completed several randomized, double-blinded, placebo-
controlled trials (RCT) of ARG therapy in children with SCD & pain requiring hospitalization in both the US &
Nigeria. These studies combined found that ARG replacement therapy (ART) has opioid-sparing effects,
improved pain scores & cardiopulmonary function, decreased pain medication use & time-to-crisis-resolution
and was associated with a shorter hospital stay compared to placebo. The PI and colleagues also observed a
dose-dependent impact of ART that improved mitochondrial function & decreased oxidative stress in children
with SCD-pain. With recent NHLBI funding for a multicenter Phase 3 RCT utilizing the Pediatric Emergency Care
Applied Research Network (PECARN), the PI plans to perform the definitive study - Sickle Cell Disease
Treatment with Arginine Therapy (STArT) to determine the efficacy & safety of ART. Pain in SCD is the leading
cause of emergency room (ED) visits & hospitalizations, associated with an increased mortality rate. There are
no current therapies to treat the underlying mechanisms of acute pain, with interventions limited to hydration &
analgesia. The PI hypothesizes that ARG is a safe & inexpensive nutritional supplement with opioid-sparing
effects in children with SCD & pain, with potential value in low-resource environments. The STArT trial will
provide essential data for product development & will ultimately help gain FDA product approval for SCD if
benefits of ART are confirmed. The results of this proposal may ultimately lead to a change in clinical practice
for patients with SCD and targets an NCCIH strategic priority of non-pharmacologic management of pain. The
PI is highly committed to performing POR focused on nutrition science & in growing her mentorship reach to
include a diverse group of undergraduates, medical students, post-doctoral fellows & junior faculty, particularly
women & underrepresented physicians in clinical nutrition research, having mentored over 40 trainees
throughout her career. During the 5-year grant renewal, the candidate will also participate in a number of
leadership & mentorship courses, choosing curricula that will help advance the candidate as an educational
leader & mentor within academic medicine. The environment at Emory University is ideal to foster these goals
and will enhance the career development of the applicant as a mentor champion in integrative medicine in
partnership with the Georgia Clinical & Translational Science Alliance, enabling her to train mentees in the field
& increase the pool of evidence-based integrative clinical scientists.

Public health relevance
Project Narrative: Pain is the hallmark of sickle cell disease (SCD), and is the leading cause of hospitalizations, emergency room visits, missed school, and is associated with an increased death rate. We found that patients with SCD and pain had low levels of the amino acid arginine in their blood, and we also demonstrated that arginine supplementation during acute pain events significantly reduced the amount of opioids needed to treat sickle cell pain in children and dramatically improved pain scores at discharge compared to placebo. We propose to investigate the benefits and safety of arginine for the treatment of patients with SCD and pain in a randomized, placebo-controlled clinical trial where neither the patient nor the clinical team know which therapy the patient is receiving, since Arginine is a promising nutritional therapy that could change the way we treat acute pain in SCD.